THE IDENTIFICATION AND CHARACTERIZATION OF HUMAN GENES ASSOCIATED WITH NEOPLASIA

We have continued our efforts to identify and characterize frequent genetic changes associated with primary human breast tumor DNAs. The int-2 gene is related to the fibroblast growth factor gene family. It is frequently activated by mouse mammary tumor virus- induced insertional mutagenesis in mouse mammary tumors. We have found that int-2 is amplified 2- to 15-fold in 16% of human breast tumors (n=118). This genetic alteration has a highly significant association (P less than or equal to 2 x 10-6) with patients who subsequently developed a local recurrence or distal metastasis. The c-erbB-2 gene is related to the gene encoding the epidermal growth factor (EGF) receptor. We found that 10% of the breast tumor DNA contain an amplification of c-erbB-2. In contrast to one published report from another laboratory, we did not find a significant association between this mutation and the patients' prognosis.